MAPPING AUTOIMMUNE PHENOTYPES IN MULTIPLEX FAMILIES (MADGC 2)

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. 1.Establish multiplex family collections for association mapping 2.Genome wide association mapping of autoimmune disease in multiplex families. 3.Replication studies and gene identification 4.Genetic associations with intermediate (autoantibody) phenotypes